Patient Derived Cancer Model (PDCM) Finder

Project Summary - Patient Derived Cancer Model (PDCM) Finder
An area of significant growth in cancer research is the diversity and volume of low passage human cancer cell
lines, three-dimensional organoid cultures and patient-derived tumor xenografts (PDX) known as Patient Derived
Cancer Models (PDCM). This project will therefore aggregate, harmonize and integrate diverse PDCM data,
extending our previous resource PDX Finder by inclusion of novel models, making these FAIR (Findable,
Accessible, Interoperable, Reusable) compliant and cloud accessible, for example in the NCI Research
Commons. PCDM Finder will address challenges with searching over many repositories for models, incompatible
standards that make analysis and reuse of models difficult, molecular datasets annotated with insufficient
information that prevent cloud-based analyses and the need for more community awareness in providing FAIR-
compliant data to maximize the impact of their work. To address these challenges, PDCM Finder has 3 tasks: 1)
Enable cancer researchers to Find and Access models by enhancing our current resource to deliver the PDCM
Finder, 2) Aggregate and Integrate PDCM datasets to ensure Interoperability and Reusability for the NCI Cancer
Research Commons, and 3) Perform targeted community outreach during all stages of the project to determine
and prioritize requirements, guide development and promote the PDCM Finder resource. The expected
outcomes are users will be able to find, group and locate PDCM models of all types based on community defined
attributes (e.g. diagnosis, oncogenic mutation); explore and download molecular data summaries and drug
response data from the PDCM portal; aggregate and analyze harmonized PDCM molecular datasets on cloud
based analysis platforms. This will accelerate cancer research by allowing doctors and researchers to find PDCM
data that best matches their patients and/or research questions and explore new therapeutic avenues for
patients.

Public health relevance
Project Narrative - Patient Derived Cancer Model (PDCM) Finder Patient derived Cancer Models (PDCM) are developed by taking tumors out of cancer patients and processing them to create cell lines that grow in a dish, “organoids” that recreate a min-version of the tumor in culture, or patient derived xenograft mouse models where the tumor is transplanted into a mouse that lacks an immune system. All three models are used as tools to study how tumors grow and give scientists and doctors the opportunity to test new therapies. This project proposes to collect and combine data across all three model types to allow researchers to find models for their own research and to reuse existing data to enable new discoveries into tumor biology and understand why cancers develop resistance to drugs.